The KChIP2-JNK2 axis as a therapeutic target for sudden cardiac death

Project Summary
Half of heart failure (HF) patients die suddenly, termed as sudden cardiac death (SCD), while HF affects over 5
million people in the United State alone. The current ACC/HF/AHA guidelines recommend implantable
cardioverter-defibrillator (ICD) therapy for the secondary prevention of SCD and primary prevention in HF
patients. However, significant mortality benefits in ICD implanted HF patients was not shown in randomized
clinical trials. Therefore, development of effective therapies is urgently needed. HF myocardium exhibits
electrophysiologic pathological remodeling that underlies the development of non-reentrant mechanisms
(triggered activity) as well as slowing of conduction in nonischemic HF human hearts that underlie development
of reentry. Sarcoplasmic reticulum (SR) Ca2+ mishandling impairs excitation-contraction coupling, to play a key role
in triggered arrhythmia in HF. Our group recently discovered a previously unknown form of kinase-on-kinase
crosstalk where JNK2 enhances CaMKII gene expression and activity, CaMKII-regulated SR Ca mishandling
(leak/overload), arrhythmic Ca activities, and triggered delayed afterdepolarization (DADs) in the heart. We
further demonstrated a JNK2-specific action (independent of CaMKII) in SR Ca overload via enhanced SERCA2
Ca uptake, which exacerbates the JNK2-CaMKII-evoked diastolic SR Ca leak and arrhythmogenesis. In addition,
we found that JNK2 downregulates gap junction Cx43 gene expression and impairs cell-to-cell communication,
which promotes reentrant substrate to sustain triggered activities. Our pilot studies show that JNK2 is markedly
activated and upregulated in explanted failing left ventricles (LV) from dilated cardiomyopathy (DCM) patients
compared to healthy control hearts suggesting that JNK2 could be an unexplored contributor to SCD in HF. Although
our preliminary data suggest a key implication for JNK2 in the mechanisms leading to SCD, the upstream
pathway leading to this upregulation of JNK2 remains unknown. Importantly, downregulation of the Potassium
Channel Interacting Protein, KChIP2, has been linked to arrhythmias and SCD. In the absence of KChIP2 there
is enhanced susceptibility to ventricular arrhythmias, while restoring KChIP2 expression in a rodent model of
hypertrophy delayed the progression to HF and reduced arrhythmias. Importantly, we demonstrated that KChIP2
is found in the nucleus where it can act as a transcriptional repressor suggesting it could contribute to arrhythmia
mechanisms through transcriptional regulation of cardiac genes. Our preliminary data suggest that KChIP2 can
bind and repress the expression of JNK2. Thus, our central hypothesis for this proposal is that the KChIP2-JNK2
axis plays a critical role in mechanisms leading to arrhythmias and SCD. This proposal will aim on answering
two important questions: 1) how does KChIP2 regulate JNK2 expression? 2) how does the KChIP2-JNK2 axis
promote SCD in HF? Importantly, we will test therapeutic interventions of overexpression of KChIP2 and/or
inhibition of JNK2 as novel anti-arrhythmia strategies for HF patients.

Public health relevance
Project Narrative Heart failure myocardium exhibits electrophysiologic pathological remodeling that underlies the development of arrhythmias leading to sudden cardiac death. Here we aim to delineate the mechanisms behind KChIP2 transcriptional repression of the stress kinase JNK2 gene and the possible causal role of increased/activated JNK2 to arrhythmia mechanisms and sudden cardiac death onset. The outcomes of this proposal will establish the therapeutic potential of KChIP2 gene transfer and/or JNK2 inhibition as prospective anti-arrhythmia interventions for a translational path toward future arrhythmia therapies in HF patients.